Collaborative Research Fund: Development and validation of a viral vector for targeted inhibition of DG granule cells

PROJECT SUMMARY/ABSTRACT
Epilepsy is one of the most common neurological disorders. Approximately one third of patients are drug-
resistant, underscoring the need for alternative therapies. One of the biggest challenges in developing disease-
modifying therapies is the limited understanding of the underlying mechanisms behind the initiation and
propagation of seizures. We propose to develop a novel, translational viral vector that targets dentate gyrus (DG)
granule cells, which have been shown to act as a seizure gate. We will make use of a promoter specific to DG
granule cells, Prospero-related homeobox 1 (Prox-1), to selectively express a calcium indicator in these cells.
We expect that the project will provide an invaluable tool to study behaviors of the seizure gate of DG granule
cell. We will first develop the viral vector in the US lab (Aim 1). We will then examine activity of DG granule cells
through fiber photometry in freely behaving mice during spontaneously recurring seizures in the
intrahippocampal kainic acid (IHKA) model of temporal lobe epilepsy in Japan lab (Aim 2). We believe that this
project can help us better understand the mechanisms at play during seizures, as well as improve treatment in
patients with drug-resistant epilepsy. In addition to its utility in epilepsy, a Prox1-driven expression vector could
have potential applications in Alzheimer’s disease and neuropsychiatric disorders as well as in lymphatic and
cancer research.
This international collaboration is a unique combination of the expertise of the two groups, namely development
of molecular tools and applications of such new technologies in an animal model of epilepsy. This effort will
significantly enhance the goals of the parent R21 award.

Public health relevance
PROJECT NARRATIVE Approximately one third of patients with temporal lobe epilepsy do not respond to currently available antiseizure drugs, and many are not candidates for surgical resection. Inhibition of activity of a specific cell type in the hippocampus effectively arrests seizures in a rodent model of temporal lobe epilepsy, but translation of this approach is being hampered by the inability to specifically target these cells in human patients as it is impossible to modify genes as in model animals. In this project we will develop a viral vector to specifically deliver a transgene to the hippocampus in non-genetically modified mice with the goal of developing a novel and translatable gene therapy to stop seizures in patients with drug-resistant temporal lobe epilepsy.